Path C Indiana Produce Safety Cooperative Agreement Program (CAP)

Project Summary
Over the next project period, the Indiana Produce Safety Team plans to take a research-to-
practice approach with the intent to further advance the current program standards, ensure the
Produce Inspection Program is consistent with national standards, and promote acceptance and
understanding of rule requirements among growers through education and outreach activities.
It is also expected that with detailed planning, collaboration with industrial partners and other
regulatory agencies, Indiana can further advance its efforts towards achieving a national
integrated food safety system through the implementation of the FDA Produce Safety Rule
(PSR) (21 CFR 112).
Indiana Department of Health (IDOH), as a Path C applicant, is committed to implement the
PSR and conduct produce safety inspections under Indiana state authority (Indiana Code § 16-
42-3.5). This statute can be found at http://iga.in.gov/legislative/laws/2020/ic/titles/016/#16-
42-3.5 with key provisions including the following: Adoption of FDA’s Produce Safety Rule by
reference that authorizes the IDOH regulatory team to implement the PSR as per 21 CFR 112
standards (may not be more stringent than written), and the state may suspend the
implementations of the rule if the federal government does not provide sufficient funds to
administer and enforce the requirements in 21 CFR 112.
Regarding Sprout Inspections (Subpart M), the Indiana regulatory team plans to continue to
follow the lead of the FDA Detroit Office of Regulatory Affairs to set the ongoing inspection
schedule. The Indiana Produce Safety Team’s goal is to begin sprout farm inspections once
inspectors are sufficiently trained.
Lastly over the next 5 years, IDOH aims to verify 100% of the 2088 produce farms using the
2017 USDA National Agricultural Statistical Services (NASS) data as a baseline, educating
and/or connecting with 1773 produce farms, and use the “Inspection Frequency” and “Risk-
Based Prioritization” models to inspect farms in the top 30% of the prioritization list every three
years, and the remaining every five years. Annual target farm inspections are estimated at 20%
of Indiana’s non-exempt covered farms, which is approximately 54 farms based on the 2017
NASS data, and with 11 follow-up inspections. Indiana plans to follow the Band 5 for “Education
and Inventory” and Band 6 for “Regulatory” funding assignments for Year 1 and 2, and then
revise its ongoing operational needs based on the updated farm inventory development data.

Public health relevance
Project Narrative Between 2021 and 2026, based on the resources provided by the United States Food and Drug Administration (FDA) Cooperative Agreement PAR-21-127 and guidance issued by the National Association of State Departments of Agriculture (NASDA) model Produce Safety Implementation Framework, it is the goal of the Indiana Produce Safety Team to continue to advance the operation of the regulatory program as a Path C grantee, to ensure uniform and consistent application of the Produce Safety Rule (21 CFR 112), and most importantly to advance efforts for a national integrated food safety system.